Multiparametric Mapping of Knee Joint with Magnetic Resonance Fingerprinting

PROJECT SUMMARY
Osteoarthritis (OA) is a degenerative joint disease, affecting more than 27 million people in the United States
alone. This large affected population and the severe consequent debility of OA lead to significant expenses to
the health care system. OA is characterized by biochemical, structural and morphologic degradation of
components of the extracellular matrix (ECM) of articular cartilage. The ECM is composed of primarily two groups
of macromolecules including proteoglycan (PG) and collagen fibers. Early diagnosis of cartilage degeneration
would require the ability to non-invasively detect changes in PG concentration and collagen integrity before
morphological changes occur. T1, T2 and T1ρ relaxation times are affected by these pathological processes and
are the most widely used biochemical cartilage MRI sequences worldwide.
The overarching goal of this proposal is to develop, optimize, and translate the magnetic resonance fingerprinting
(MRF) framework, which allows for simultaneous, morphological, volumetric, and quantitative multiparametric
mapping [T1, T2, T1ρ, B1+ and proton density (PD)] to the knee joint in a much shorter time (≤10 minutes) than
conventional individual parametric mapping on a standard 3T clinical scanner. The proposed MRF-based
multiparametric mapping approach can be easily incorporated into routine research/clinical protocols for multi-
tissue assessment of the knee joint without exogenous contrast agents and could serve as future imaging
biomarkers for disease modifying therapies for OA.

Public health relevance
PROJECT NARRATIVE The current proposal will establish a powerful non-invasive imaging biomarker based on development of rapid, simultaneous multiparametric relaxation mapping of knee joint with magnetic resonance fingerprinting (MRF).